Genomic and transcriptomic analysis to dissect the role of the intrinsic resistance factor RarA in carbapenem resistance in Klebsiella pneumoniae

Project Summary
Antibiotic resistance is a rapidly escalating global health crisis and is predicted to cause 10 million deaths per
year by 2050 without sufficient intervention.1 We have made strides in the arms race against antibiotic
resistance through the availability and feasibility of bacterial whole genome sequencing (WGS), which has
enabled us to connect bacterial genotypes to resistance phenotypes; however, many gaps in knowledge
remain about the genetics of bacterial resistance.2 In this proposal, I focus on carbapenem resistance (CR) in
Klebsiella pneumoniae (Kp), which is difficult to treat and leads to high rates of morbidity and mortality.
Previous work has shown that most CR in Kp is explained by a combination of enzymes that hydrolyze
antibiotics and mutations in porins, decreasing cellular permeability to antibiotics.3,4 However, we find that
levels of CR are often higher than expected based on the strain’s genotype. We have observed for the first
time that overexpression of the transcription factor RarA is associated with unexplained, high-level CR.
However, RarA’s cellular function and its role in antibiotic resistance is poorly understood. The goal of the
proposed research project is to investigate the genetic pathways through which RarA modulates CR and
identify natural genetic variation associated with high-level CR. To address this goal, I will leverage a unique
collection of Kp clinical isolates with associated whole genome sequencing data and antibiograms collected by
our group. I propose two specific aims: (1) define the RarA regulon and its role in CR by using RNA-Seq on
RarA deletion and overexpression strains to identify downstream effectors, followed by perturbation of these
effectors to assess their contributions to CR; and (2) elucidate how natural variation in the RarA regulon
interacts with known resistance determinants to contribute to CR. We will use regression models to quantify the
relationship between genetic variations in RarA and its repressor OqxR, and their effects on RarA expression,
and apply statistical models to understand how these variations, along with known resistance determinants,
contribute to CR. This research will provide insights into the role of RarA in CR, improving our capacity for
diagnostics, treatment, and surveillance of CRKp.

Public health relevance
Project Narrative This project investigates how a genetic regulator, RarA, contributes to antibiotic resistance in Klebsiella pneumoniae, a bacterial pathogen that is often difficult to treat. By understanding the role of RarA in resistance, we aim to improve our ability to track and predict resistance, identify new drug targets, and optimize treatment strategies for patients with carbapenem resistant Klebsiella pneumoniae infections.